NIDA DEVELOPMENTAL STUDIES BIOREPOSITORY AND ANALYSIS CENTER. SEPTEMBER 17, 2021 - SEPTEMBER 16, 2022. N01DA-21-5588. TASK ORDER 75N95022F00001 (TO2).

Covers any work in the Statement of Work for Contract No.: 75N95021D00023.